Origins, Functional, and Evolutionary Consequences of Genomic Variation

Project Summary
Genetic variation is the central component of all major evolutionary processes. Differences among individuals’
genomes contribute to phenotypic variation including disease susceptibility and the evolution of adaptation.
The exceptional growth in genome sequencing technologies and concomitant acceleration in the development
of bioinformatic software has the potential to address longstanding questions about the evolution of genomes.
Our lab will continue to lead this scientific endeavor by developing a range of statistical, computational, and
experimental techniques. In particular, we will develop uniquely scalable computational methods to infer and to
understand the relationships among densely sampled populations such as SARS-CoV-2. We will develop
computational techniques to study adaptation and the underpinning of genetic isolation using genomes from
admixed populations. Our group will leverage an established genome engineering technique to rearrange parts
of genomes that have remained structurally static for more than 100 million years and to determine what
molecular and fitness effects underlie this maintenance. Finally, our team will leverage natural variation in
intron abundance to determine the molecular consequences and fitness impacts of massive intron gain.
Results from this work have profound implications for understanding the origins, effects, and ultimate
consequences of genetic variation on evolutionary outcomes in natural populations.

Public health relevance
Project Narrative: This broad research program will investigate the origins, maintenance, and consequences of genetic variation. We will marshall a range of computational, statistical and experimental methods to study the origins of genetic novelty at the level of individual positions in the genome and genome structure itself. We will investigate molecular consequences and fitness effects that drive new variation to be lost or persist in natural populations.